NIDA CENTER FOR GENETIC STUDIES. MARCH 14, 2023 - MARCH 13, 2024. N01DA-23-7787. TASK ORDER 75N95023F00001 (TO1).

NIDA Center for Genetic Studies (Rutgers)
The National Institute on Drug Abuse, in collaboration with the National Institutes of Health, has established the NIDA Center for Genetic Studies, also known as the NIDA Genetic Repository, under a contract to Rutgers University, via Sampled, and its subcontractor, Washington University School of Medicine, to produce, store, and distribute clinical data and biomaterials (DNA samples and cell lines) available in the NIDA Genetics Initiative.